Core C: Recruitment, Retention And Cohort Management Core

CORE C: RECRUITMENT, RETENTION AND COHORT MANAGEMENT
ABSTRACT
The Recruitment, Retention and Cohort Management Core will coordinate all aspects of creating and
maintaining an enrolled Longitudinal Study Population of 10,000 dogs. In this complex nationwide study,
effective communication with owners and veterinarians across diverse sites is paramount to facilitate accurate
and timely submission of data in many forms. To ensure success, this core will be governed by the Chief
Veterinary Officer, Dr. Kate Creevy, at Texas A&M College of Veterinary Medicine & Biomedical Sciences
along with Dr. Daniel Promislow, the PI of the U19 Research Program and co-Investigator for this Core. The
Recruitment, Retention and Cohort Management Core will achieve its overall goals through a set of three
specific aims. Specific Aim 1 will construct, manage and maintain a cohort with sufficient power to address the
central hypotheses of the U19. This will include development of cohorts that include an appropriate balance of
breed, sex and age for the study segments, and that fairly represent the diversity of dog owners in the United
States. The second Specific Aim will develop and maintain protocols to make it possible to collect medical
records data and enrolled dog clinical measurements and assays with minimal burden on participants. Core C
will create and distribute paper and electronic recruitment materials to veterinarians, dog owners and
interested groups; it will coordinate enrollment requests and select participants for all U19-related studies; it will
ensure Informed Consent is obtained from owners and archived; and it will monitor timely completion of study-
related physical examinations, questionnaires and laboratory assessments and submission of data generated
by these events. Finally, Specific Aim 3 will create the infrastructure needed to respond to questions and
concerns from participating owners and veterinarians regarding completion of study-related tasks; and to
oversee ongoing communication with and among participants.